Bioinformatics Core

Project Summary – Bioinformatics Core
The SC INBRE Bioinformatics Core uses a variety of approaches to promote Bioinformatics across the SC
INBRE Network. The Bioinformatics Core will continue to focus efforts in three areas – training, services, and
research – to facilitate the growth of research in genomics, proteomics, and personalized medicine. In order to
facilitate a more distributed model of developing the Bioinformatics workforce across the state of South
Carolina, the core will implement various models of training. It will continue to support the traditional
mechanisms of training students, scientific staff and faculty through the development of a sequence of
workshops that are aimed to equip a typical life science researcher with expertise needed to embark on
Bioinformatics research. In addition, the Bioinformatics Core will create customized training courses for any
interested network institutions to meet the specific needs of their researchers. These custom courses will serve
as the foundation for courses that can be adopted by the faculty at PUIs to enhance their Bioinformatics
curriculum. The Bioinformatics core will continue to provide data storage, data warehousing, data hosting, host
websites, and provide computing services. In addition the core will continue to provide support for genomic and
proteomic data analysis including transcriptome/genome assembly, differential gene expression, and
comparative genomics and will provide SC INBRE investigators for designing experiments and assistance with
grant writing. The Bioinformatics Core will continue to support Bioinformatics Pilot Projects (BIPP) in SC
INBRE IV while introducing Student Initiated Research Projects (SIRP). Students (graduate and
undergraduate) will propose projects in collaboration with a faculty mentor who will oversee the overall
progress of the project. Students will attend a workshop to receive instructions related to best practices in grant
writing and will be encouraged to collaborate with an existing BIPP or DRP funded investigator. The Core will
continue its support of access to research resources for all SC INBRE network members by continuing its
support for library services to all PUI faculty. The Core director will routinely assess the Bioinformatics needs of
the SC INRBE network by visiting each campus and meeting with faculty and students in addition to feedback
received from training courses/workshops. As part of its research efforts, the Bioinformatics Core will continue
to develop and share Bioinformatics tools with researchers across the SC INRBE network.